The University of Chicago and Northwestern University Pre-doctoral Health Services Research Program

PROJECT SUMMARY/ABSTRACT
The University of Chicago (UC) is requesting continued support from the Agency for Healthcare Research and
Quality (AHRQ) for the National Research Service Award (NRSA) program entitled the University of Chicago
And Northwestern University Predoctoral Health Services Research Program (hereafter, UCANU Predoctoral
HSR Program). The program will provide two to three years of support to outstanding candidates from
predoctoral programs from both UC and NU, leading to careers in health services research. UC has been an
ideal site in which to provide broad-based training in health services due to the extraordinary strength of its
faculty in health services research and in the social science, biomedical, and statistical disciplines upon which
HSR draws. The high caliber of students at UC has been a notable strength of the ongoing and proposed
programs. Likewise, Northwestern University's (NU) Health Sciences Integrated PhD Program (HSIP) has
successfully recruited and trained students in its health services and outcomes research track, drawing
students from a broad array of health professional fields and research disciplines. This joint partnership of UC
and NU, which began in 2013, has proven to be highly successful during these past 5 years by offering a
unique opportunity for the UCANU Predoctoral HSR Program trainees to leverage the extensive resources,
expert faculty, and dedicated mentors across both institutions. The support of AHRQ and the availability of
NRSA funding for trainees in the past nineteen years have helped each institution to expand upon the existing,
successful research and training programs in HSR by making each site more appealing to students with such
interests and attracting even more of each institution's talented and promising students into the field. In this
application, we propose to continue to advance our training by enhancing our didactic and experiential
offerings to better prepare trainees to function as key members of learning health care systems, leveraging
opportunities for the practical application of HSR at both UC and NU while preparing trainees to apply their
HSR training throughout the health care system.

Public health relevance
PROJECT NARRATIVE The University of Chicago And Northwestern University Predoctoral Health Services Research Program, referred to as the “UCANU Predoctoral HSR Program,” proposes to build and expand upon the first 5 years of success of a unique, joint predoctoral training program to prepare social scientists and clinicians with the knowledge and methodological skills to address the most pressing issues of the US healthcare delivery system.